The Role of Implicit Bias on Outcomes of Patients with Advanced Solid Cancers

Project Summary
Despite advancements in healthcare and cancer treatments, a notable disparity in cancer outcomes persists
among different racial and ethnic groups. While factors like healthcare insurance expansion, early detection,
new treatments, and smoking cessation have contributed to increased survival rates, African Americans and
ethnic minorities continue to face disparate outcomes. The American Cancer Society highlights that African
Americans experience later diagnoses, lower screening rates, greater illness burden, the highest death rates,
and the shortest survival times compared to other racial groups.
Clinical trials have the potential to enhance outcomes, nonetheless, disparities persist in the enrollment of
Black and Hispanic individuals in cancer clinical trials. Over the past two decades, there has been a significant
decline in the participation of minority patients in clinical trials, and this gap has widened further in the
aftermath of the COVID-19 pandemic.
Efforts to address these disparities have included interventions like provider bias training and various methods
to boost enrollment of racial and ethnic minorities in clinical trials. However, the effectiveness of these
interventions remains limited without widespread implementation. While patient-clinician communication is
identified as a crucial factor in improving clinical trial accrual, existing studies lack comprehensive geographical
and demographic testing.
This study aims to fill these gaps by employing a tool based on community input and co-developing suitable
criteria for scoring the quality and content around clinical trial discussions. Recognizing the impact of effective
communication on overall health, healthcare literacy, treatment adherence, trust-building, and reducing
disparities, the study seeks to provide clinicians with tools to facilitate discussions with minorities about cancer
clinical trials, addressing a critical need in the current landscape of cancer care. The importance of this study
lies in its exploration of this phenomenon in a manner that has not been extensively investigated, offering a
unique perspective on the challenges faced by minority populations in accessing and participating in clinical
trials.
This supplement will provide essential experience, partnerships, and preliminary data for my career
development. It will be a catalyst for applying for an NIH R-level grant to investigate a communication
intervention for improving clinical trial accrual among minoritized cancer patients. The mentorship plan, led by
an experienced team dedicated to supporting underrepresented researchers, will help me achieve my goal of
becoming an established researcher through regular meetings, training, and guidance.

Public health relevance
Project Narrative The outcomes of minoritized patients with advanced cancer remain poor despite many attempts at improving equity. This proposal will employ a tool based on community input and co-developing suitable criteria for scoring the quality and content around clinical trial discussions. Recognizing the impact of effective communication on overall health, healthcare literacy, treatment adherence, trust-building, and reducing disparities, the study seeks to provide clinicians with tools to facilitate discussions with minorities about cancer clinical trials, addressing a critical need in the current landscape of cancer care.